Role of Heat Shock Protein 70 as a Mediator and Therapeutic Target in T-cell Lymphomas

PROJECT SUMMARY / ABSTRACT
Non-Hodgkin lymphoma (NHL) is the most frequent hematologic malignancy, and is divided into B-cell and T-
cell lymphoma subtypes. B-cell NHL patient outcomes have improved dramatically with the development of
new targeted therapies, but similar progress has not been made against peripheral T-cell (PTCL) and
cutaneous T-cell (CTCL) lymphomas. Indeed, patients who relapse after initial PTCL therapy have a less than
1 year median survival, and patients with the CTCL subtype mycosis fungoides that is advanced, or that has
Sézary syndrome with skin, blood, and lymph node disease, have a median survival of one year from
diagnosis. Thus, the identification of novel targets and drugs with activity against PTCL and CTCL will be
critical for this area of unmet medical need to help cure these diseases, which have not been a major focus for
industry-sponsored research due to their heterogeneity and lower incidence. To address this challenge, we
investigated the cell surface proteome of PTCL and CTCL cell lines and found Heat shock protein 70 (HSP70)
to be highly expressed. Then, we developed monoclonal antibodies to human HSP70 and found that one,
designated clone 239-87, recognized HSP70 on PTCL and CTCL cells but not on normal T-cells. To convert
239-87 into a drug, we linked it to monomethyl auristatin E (MMAE) to generate an antibody-drug conjugate
(ADC), which we found inhibited PTCL and CTCL cell line growth as well as and, in some cases, better than
brentuximab vedotin (BV), another ADC already approved for T-cell NHL. Also, 239-87-MMAE showed
synergy when combined with other therapies already used against PTCL and CTCL, including the deacetylase
inhibitor vorinostat and the ADC BV. Next, we used the 239-87 single chain variable fragment sequence to
create chimeric antigen receptor (CAR) guided T-cells, and these were activated in the presence of T-cell NHL
cell lines. Finally, in a cell line-based xenograft, the 239-87-MMAE ADC cured mice with an aggressive PTCL
variant. Our preliminary data support the central hypothesis that targeting cell surface HSP70 using an ADC or
CAR T-cell therapy approach will be both novel and effective against PTCL and CTCL, and could ultimately
improve patient outcomes. In order to test this hypothesis, we propose three aims: (1) To investigate the
differential expression of HSP70 in PTCL and CTCL models, including in primary patient samples, and
to perform studies to identify pathways in these cancer cells that regulate HSP70 expression; (2) To
identify the best ADC and CAR T-cell construct based on our 239-87 antibody, and explore which
combinations will show greatest synergy; and (3) To use in vivo models, including patient-derived
xenografts, to determine effective strategies against these lymphomas that will work best in the
clinic. Taken together, successful completion of these studies will increase our understanding of the role of
HSP70 in PTCL and CTCL biology, provide the rationale to take these approaches to the clinic for patients with
PTCL and CTCL who are looking for novel therapies and, ultimately, improve their outcomes.

Public health relevance
PROJECT NARRATIVE Non-Hodgkin lymphoma (NHL) is the most common cancer that develops from cells of the blood system, and while outcomes for B-cell lymphoma patients have improved dramatically, similar progress has not been made against peripheral T-cell (PTCL) and cutaneous T-cell (CTCL) lymphomas, where survival after relapse in the former, and in some subtypes of the latter, even after diagnosis, remains less than one year. We identified Heat shock protein (HSP)-70 as being highly expressed by models of both PTCL and CTCL, developed a panel of antibodies of which one, known as clone 239-87, specifically recognizes HSP70 only on cancerous T- cells but not normal T-cells, and found that this antibody showed promising activity against both PTCL and CTCL models as an antibody-drug conjugate (ADC), and as a chimeric antigen receptor (CAR) guided T-cell. Further studies are proposed that will broaden our understanding of the role of HSP70 in T-cell lymphomas, study the activity of various HSP70-targeted ADCs and CAR T-cells both alone, and in rationally designed combinations against cell lines, and validate the efficacy of the best approaches in vivo, with the ultimate goal of moving at least one of these to the clinic to improve outcomes of the many patients with PTCL and/or CTCL who need new treatment options.